Quantum Dynamic Investigations of Redox in Biology

Project Summary
Establishing a fundamental understanding of redox processes in biology is a key challenge with the potential to
transform research in areas ranging from the development of biomimetic materials for efficient energy harvesting,
small molecule drug design to mitigate disease pathways, and even in the search for quantum materials that exhibit
sensitive control of electrons and spin dynamics. While electronic structure theory and multiscale methods like
QM/MM can uncover experimentally inaccessible intermediate structures and even provide insights into some
thermodynamic properties these methods are inherently static and do not account for quantized nuclear motion.
Using the path integral formulation of quantum mechanics, we will build a theoretical framework that retains
the computational efficiency of classical molecular dynamics but that can elucidate kinetic factors – uncover
reaction pathways and compute rates – while taking into account the inherently quantum nature of charge transfer
by capturing zero-point energy, tunneling, and even quantum coherence effects. Working with experimental
collaborators, we will build a broadly applicable simulation toolbox for the characterization of redox processes
in biology and we will demonstrate them on model systems including a nitrification enzyme, a multi-metal center
drug candidate, and a radical relay protein that exhibits long range electron transfer (ET). These studies will allow us
to answer key outstanding questions in redox biology: (i) Can we ‘see’ the sequence of electrons and protons transfer
events in enzyme active sites? What residues control the order and efficiency of the transfer events? (ii) How does
the environment (solvent, co-localized small molecules, metal centers, crowding) affect redox reactivity? Can we
identify pathways for decoherence and energy dissipation and corresponding control strategies? (iii) What are the
key dynamically and statistically correlated fluctuations that drive long range ET? Can we identify fundamental
design principles for efficient long range ET?

Public health relevance
Project Narrative Redox processes like electron and proton transfer are central to the functioning of biological systems including photosynthesis and enzyme catalysis. Understanding, at the level of atoms and electrons, how these reactions proceed is an important frontier with implications for progress in areas ranging from biomimetic materials for quantum computing and energy applications to small molecule drugs for disease. New theoretical methods for quantum dynamics will allow us to uncover key interactions that drive these charge transfer processes and make them more efficient.